An Informatics Platform for Objectively Quantifying Electric Power Wheelchair Usage for those with Alzheimer's Disease, Alzheimer's Disease Related Dementias, and Cognitive Impairments

Project Summary/Abstract
Proposed is an informatics platform for caregivers of wheelchair operators with or at risk of developing
Alzheimer’s disease (AD), Alzheimer's Disease Related Dementias (AD/ADRD), and cognitive impairments.
Significance: Many older adults have chronic health conditions that limit mobility and, thus, wheelchair use is
essential for maintaining independence. However, when an older wheelchair user exhibits signs of cognitive
decline related to developing dementia, caregivers must make hard, subjective choices trading safety with
independent mobility. Currently there is no system that can monitor and quantify subtly diminishing driving
abilities. Hypothesis: We hypothesize that direct observation of a wheelchair user’s driving behavior can
quantitatively distinguish between normal and impaired operation. Such a system could inform caregivers
before an incident that intervention may be necessary and wheelchair use should be reviewed and possibly
suspended. Conversely, it may allow many patients to continue wheelchair use by providing caregivers a
consistent, in-community measure of a patient’s abilities reflecting their current cognitive state. Specific Aims:
In Phase II, IDL and its collaborators will: (1) Develop a production-ready system, (2) Perform a monitoring
study with powered wheelchair users (non-clinical trial), and (3) Evaluate system and algorithm performance
quantifying driving habits and cognitive changes.

Public health relevance
Project Narrative Cognition traditionally hasn’t been the first focus of wheeled mobility professionals working with patients diagnosed with dementia, spinal cord injury (SCI), multiple sclerosis (MS), amyotrophic lateral sclerosis (ALS) or a traumatic brain injury (TBI) even though cognitive impairments are either a common or the primary characteristic of these conditions. Operating a wheelchair, whether manual or powered, is a complex task requiring skills in navigation, planning, and problem solving and wheelchairs can be potentially dangerous to the user and other people in the environment. When a wheelchair user exhibits signs of cognitive decline or impairment, caregivers must make hard, subjective choices favoring safety over independent mobility.